Howard University Research Center for Minority Health and Health Disparities

Program Director/Principal Investigator (Last, First, Middle): Ozra Dehkordi, Ph.D
ABSTRACT
The most frequent cause of death associated with opioid overdose is respiratory depression. The respiratory
depressant effects of opioids are mainly mediated by G-protein-gated inward rectifying potassium channels
subunit 2 (GIRK2) expressed by the respiratory rhythm generating neurons of the pre-Bötzinger complex.
GIRK2 are also known to be implicated in opioid-induced analgesia. However, biochemical and metabolic
changes associated with opioid activation of GIRK2 in the pre-Bötzinger and brainstem pain sensitive sites such
as rostral ventral medulla (RVM), is still unknown. In the present study in mice, we hypothesize that 1) the
metabolomic changes in the RVM and pre-Bötzinger complex associated with long-term subcutaneous
morphine administration, is due to activation of GIRK2 channels expressed by pain sensitive cells of the
RVM and neurokinin-1 receptor (NK-1R) expressing rhythm generating cells of the pre-Bötzinger
complex; and that 2) this activation leads to an imbalance between excitatory and inhibitory
neurotransmitters and their metabolites in the immediate vicinity of pre-Bötzinger complex and RVM.
We will test this hypothesis using in vivo proton magnetic resonance spectroscopy (1H MRS) in wild-type and
GIRK2 heterozygous (GIRK2+/-) mutant mice. We will analyze changes in the concentration of glutamate,
glutamine, GABA, glycine and other metabolites in the pre-Bötzinger complex and RVM before and 6-7 days
after subcutaneous implantation of morphine (75 mg pellets) and/ or placebo pellets (control). The results will
provide valuable information regarding cellular and biochemical changes associated with morphine activation
of GIRK2 at the pre-Bötzinger and RVM. The results also has the potential to enable the study of brain
metabolites involved in opioid-induced analgesia at the RVM and opioid-induced respiratory depression at the
pre- Bötzinger complex.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Dehkordi, Ozra Project Narrative: One of the most widely recognized and potentially life-threatening side effects of opioids, used for the treatment of moderate-to severe pain, is respiratory depression. The present study will use in vivo magnetic resonance spectroscopy studies to identify morphine- induced metabolic changes in the respiratory centers of the brain. The identification of changes of metabolites may help in the development of new treatment strategies to overcome morphine-induced respiratory depression. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page